RENAL AND SKELETAL RESISTANCE TO PARATHYROID HORMONE

Abnormal responses to hormones that control calcium metabolism. Evaluation of patients for pseudohypoparathyroidism with skeletal sensitivity to the actions of parathyroid hormone despite renal resistance to P.T.H.